Acquisition of a Focused Ion Beam Scanning Electron Microscope with cryo-stage

Project Summary
This proposal requests funds to acquire a Focused Ion Beam Scanning Electron Microscope (FIB-SEM) to
support a diverse group of NIH-funded research projects at Vanderbilt University and Vanderbilt University
Medical Center. This microscope will permit three-dimensional reconstruction of entire cell volumes with
sufficient spatial resolution to observe the fine details of organelles. This volume information is essential to
understand and quantify the complex interactions of organelles and macromolecular complexes within cells. The
addition of a cryo-stage will extend the functionality of the FIB-SEM, adding ion milling of vitrified frozen cells to
permit cryo-electron tomography of macromolecular structures in situ and by cryo-SEM. The Zeiss Crossbeam
550 is a state-of-the-art FIB-SEM with a high-performance ion column (3 nm resolution and up to 100 nA of
probe current) that can efficiently perform FIB-SEM tomography and can be integrated with a Leica cryo-stage
to create thin lamella for cryo-electron tomography. Our major users will apply FIB-SEM tomography to break
new ground on NIH-funded research projects which span a wide range of problems in cell, developmental,
epithelial, intestinal, and cancer biology, among others. Projects include studies of cytoskeletal dynamics
(Tyska), assembly of cell surface features (Goldenring, Tyska), bacterial protein secretion (Lacy, Cover),
basement membrane architecture (Weaver, Hudson), and cellular membrane trafficking (Weaver, Goldenring,
Zhou). Together these investigations hold significance for our understanding of disease and illness related to
birth defects, cancer, digestive disorders, and many other human health problems. The Crossbeam 550 will be
a collaboration between the Vanderbilt Cell Imaging Shared Resource (CISR) and the Vanderbilt Cryo-EM
Facility (V-CEM) within the Center for Structural Biology (CSB). It will be administered by the Vanderbilt Cell
Imaging Shared Resource. The CISR will provide the infrastructure for introducing researchers across Vanderbilt
to these new techniques, train users in operation of the instrument, and apply an established business model to
support the long-term maintenance of the system. In summary, acquisition of the Zeiss Crossbeam 550 FIB-
SEM will allow for unprecedented volumetric imaging capabilities of biological samples at scales and spatial
resolutions not currently available to the Vanderbilt community and will facilitate research on a diverse set of
topics.

Public health relevance
Project Narrative Focus Ion Beam Scanning Electron Microscopes (FIB-SEM) are versatile instruments that can be used to resolve cellular and macromolecular complexes in three-dimensions. The Zeiss Crossbeam 550 FIB-SEM will support NIH-funded research into illnesses related to birth defects, digestive diseases, cancer, and other human health problems. There is a substantial and fundamental need for such an instrument to support the ongoing work of numerous NIH-sponsored investigators at Vanderbilt University and Vanderbilt University Medical Center, and significant University resources are pledged to ensure successful implementation.